The Rhode Island Children’s Health Equity and Development Study (ENRICHED) COHORT 1: CLOSEOUT ACTIVITIES

The Division of Population Health Research (DiPHR) conducts studies focusing on child health and human development. As part of DiPHR's mission, one area of interest is the investigation of the developmental origins of health disparities - i.e., differences in developmental outcomes between socially advantaged and disadvantaged groups. Thus, disparities typically refer to unequal health outcomes between socioeconomic and race/ethnic groups and may also exist in the context of other socially disadvantaged statuses including intellectual disability and sexual minority status.
A cohort of approximately 300 pregnant women was recruited at less than 13 gestational weeks and followed through delivery. The specific aim of the study was to investigate socioeconomic and race/ethnic disparities in parental psychopathology during pregnancy, health-related behaviors, and maternal neuroendocrine-immune and metabolic responses during pregnancy.